Macrophage and osteoclast specific targeting for the prevention and treatment of breast cancer bone metastasis

Project Summary/Abstract: I have completed DVM, MS, and PhD degrees, a surgical residency, and am now
a Post-Doctoral Research Fellow in cancer and bone genetics and biology. This K01 award will facilitate my
transition into an independent position as a tenure-track clinician-scientist studying bone metastasis and primary
bone tumors. My clinical and research training will benefit both human and veterinary clinicians and researchers
and promote the development of essential translational and comparative collaborations. Advancement towards
independence will occur by many mechanisms during this K01 award. I will obtain knowledge and skills central
to this award’s research strategy and my career goals. I will continue to hone previously learned techniques but
also receive training in new methods to study cancer biology and genetics, the tumor microenvironment, bone
biology, and metastasis. I will receive training in essential non-laboratory research skills such as grantsmanship,
scientific writing, responsible conduct of research, and mentoring. Metastatic disease is the leading cause of
breast cancer-related deaths and bone metastases occur in ~75% of patients with metastasis. In bone, cancer
cells secrete factors that 1) stimulate macrophages (MPs) to differentiate into osteoclasts (OCs) and 2) increase
osteoclastic bone resorption (lysis), leading to bone loss, pain, and fracture. Therefore, preventing the
establishment of and treating existing bone metastasis is the goal of therapy. Colony stimulating factor 1 receptor
(CSF1R) regulates the expression of the transcription factor (TF) PU.1. Our preliminary data demonstrate that
the CSF1R/PU.1 axis is a key regulator of 1) tumor-associated MP (TAM) function and 2) normal MP and OC
differentiation and function. In addition, several TFs and genes essential for OC differentiation and function have
a strong enhancer binding pattern by PU.1 resembling “superenhancers”. These enhancers are enriched for BET
proteins which bind to PU.1 to regulate key osteoclastogenic TFs. The objective of this award is to 1) investigate
the role of the CSF1R/PU.1 axis and 2) determine if superenhancers play a role, in breast cancer bone
metastasis. Our hypothesis is that the CSF1R/PU.1 axis is essential for bone metastasis and this occurs in the
context of superenhancers. We will initially assess the effects of MP-specific deletion of PU.1 on breast cancer
bone metastasis and determine genes regulated by PU.1 in both primary tumor MPs and bone metastasis MPs
and OCs (Aim 1). We will then evaluate if BET inhibition can reduce the development of, and growth of
established, bone metastasis and determine if increasing its specificity to specifically target MPs and OCs will
increase its therapeutic efficacy (Aim 2). Lastly, we will evaluate if combination therapy with the most efficacious
BET inhibitor preparation from Aim 2 and a CSF1R inhibitor targeting the CSF1R/PU.1 axis is more efficacious
against the development and growth of bone metastasis when compared to either agent alone (Aims 3 and 4A-
B). Findings could have a major impact on treatment, quality of life, and survival of bone metastasis patients.

Public health relevance
Project Narrative: Once breast cancer cells spread to bone they increase the activity of cells called osteoclasts, which are formed from cells called macrophages, leading to bone loss, pain, and fracture. A cell surface receptor on macrophages and osteoclasts called CSF1R increases the activity of a protein called PU.1, which then works with a family of proteins called BETs to increase osteoclast activity. We will determine if inhibiting 1) the communication between CSF1R and PU.1 and/or 2) BET proteins can prevent the development of, and growth of existing, breast cancer bone metastasis.